A Modular Framework for Accurate, Interpretable, and Reproducible Analysis of Long Read RNA-Seq Data

PROJECT SUMMARY
RNA sequencing is extensively used in biological and biomedical research to assess the
expression of transcripts within and across biological samples. Recent technological advances
allow sequencing of entire transcripts, enhancing isoform identification and allele expression
analysis. As with short read RNA-seq, iterative algorithm development with design
considerations towards the data and metadata infrastructure is key to support accurate scientific
conclusions and facilitate computational reproducibility for users. Many specialized bioinformatic
methods are available for long read data that are able to detect novel transcripts and to adapt
algorithms for quantification of transcript abundance to the particular characteristics of long
reads. However there is a need for easy-to-use pipelines for multi-sample analysis that can be
run by biologists or other analysts without advanced bioinformatic training, covering read
processing, feature discovery, quantification, feature aggregation, and inference/visualization.
We aim to provide such a modular pipeline with enhanced accuracy, interpretability, and
reproducibility for long read RNA-seq, easily deployable on cloud platforms such as AnVIL. The
team of investigators has substantial experience developing efficient and easy-to-use tools for
transcriptomics analysis, having designed ultra-fast algorithms for sequence read processing,
modular pipelines leveraging best-in-class methods from abundance estimation to statistical
analysis, and end-user workflows that are widely used in research labs in academic institutes
and industry. The goal of the project is to develop and enhance RNA-seq analysis tools for new
long read datasets, focusing on improving accuracy and interpretability, in particular for
multi-sample datasets. In this proposal, we will 1) expand quantification tools for long read
RNA-seq including novel models for quantification and correction for errors and technical bias;
2) simplify multi-sample analysis with high-level tools that augment processing steps, extend our
automatic provenance detection framework to support new use cases in long read, and support
data-driven feature aggregation; and 3) broaden user engagement by publishing workflows and
tutorials, and hosting in-person and virtual workshops on AnVIL. The impact of this work will be
to deliver software for long read RNA-seq that is user-friendly, integrates with existing pipelines,
and is made accessible on cloud platforms like AnVIL.

Public health relevance
PROJECT NARRATIVE RNA sequencing is a key assay in biomedical research, allowing researchers to study the role of genes in human health and disease. The proposed work will develop computational tools for processing RNA sequencing data from improved technologies, which will be broadly accessible to biomedical researchers on cloud platforms. These new tools will simplify sequencing data analysis and data re-use by other scientists, to inform human disease mechanisms and possible therapies.